Enhancing MAPK-targeted Therapy in PDX Models of BRAF-Mutant Pediatric Brain Tumors

Pediatric glioma is characterized by activation of the MAPK pathway, either through a tandem duplication of
the BRAFA locus, or through point mutations (most frequently the V600E mutation). Approximately 1400 new
cases of BRAF-activated childhood brain tumors are diagnosed annually in the US. Recent phase I/II trials have
confirmed the efficacy of MEK inhibitors ((MEKi) for teatment of these cancers. However, for tumors driven by
the BRAF(V600E) mutant patients may progress on selumetinib treatment (i.e. become resistant), or rapidly
progress if drug dose is reduced or treatment stopped (at 2 years as in the recent phase II trial). Thus, while
MEKi is effective in causing tumor regression, it is not curative. Clinical results suggest that selumetinib is equally
as effective as conventional chemo-radiation therapy, but without toxicities associated with intensive chemo-
radiation treatment. Hence, MEK inhibitors usher in a new era in treatment for these patients.
Our studies were some of the only PDX preclinical data that lead to testing of selumetinib (MEK inhibitor) in
the Pediatric Brain Tumor Consortium trial (PBTC029), with efficacy confirmed in the subsequent phase II trial
(NCT01089101). Here we propose preclinical studies that could lead to the next generation of clinical trials
building on the results from current MEKi trials. The studies proposed in this application will use a unique panel
of BRAF(V600E) pediatric brain tumor PDX models to focus on two critical issues: 1) to develop MAPK inhibitor
combinations that selectively enhance tumor cell kill in combination with radiation therapy (RT), and 2) to develop
therapeutic approaches to prevent development of drug resistance. The central hypothesis is that sensitivity
to MAPKi is a consequence of dual MAPK/TORC1 inhibition, and low-dose intermittent rapamycin can prevent
emergence of resistance to MEKi, and also to radiation therapy. These studies will also explore mechanisms of
resistance to MAPK inhibitor combinations and radiation treatment (RT), alone or in combination, and
characterize the mechanism/s by which rapamycin prevents emergence of resistance.
Our overall goal is to identify optimal MAPK/TORC1 inhibitor drug combinations that retard or prevent
emergence of drug or RT resistance, determine the mechanism/s by which rapamycin retards/prevents
emergence of MAPKi and RT resistance, and determine whether such combinations can maintain tumor control
at lower doses of RT. Potentially, the proposed studies will identify novel regimens that will be more efficacious
than selumetinib and ultimately result in the ability to reduce the RT dose in patients, thus improving long-term
outcomes and quality of life.

Public health relevance
Introduction of drugs that inhibit the MAPK signaling pathway (MAPKi) have revolutionized treatment of children with BRAF- and NF1-driven glioma. However, tumors that harbor the BRAF(V600E) mutation either become resistant on therapy, or progress rapidly if treatment is reduced, or terminated. Thus, while MAPKi cause tumor shrinkage, they are not curative. Here we propose to develop MAPKi combinations with radiation therapy (RT) and investigate combinations that retard or prevent MAPKi/RT resistance in a unique panel of BRAF-mutant glioma mouse models.